Mitochondrial regulation of stress reactivity in humans

Chronic dysregulation of physiological systems manifests systemically as allostatic load (AL) and in abnormal
stress reactivity profiles, which are features of psychopathological conditions that increase future disease risk.
But the biological basis underlying inter-individual differences in stress regulation and reactivity remains
unknown. Even among populations of healthy individuals exposed to standardized laboratory challenges, such
as the Trier social stress test (TSST), there are substantial differences in the magnitude of responses in multiple
physiological systems, including but not limited to the hypothalamic-pituitary-adrenal (HPA) axis, the autonomic
nervous system (ANS) and cardiovascular system, metabolic changes, and immune and pro-inflammatory
systems. One common factor to all stress systems is their dependence on energy supply, which fuels every
aspect of the stress response including molecular, cellular, systemic and cognitive/psychological functioning. At
the cellular level, energy is provided by mitochondria, unique organelles that populate the cell cytoplasm and
contain their own genome, the mitochondrial DNA (mtDNA), that is essential to mitochondrial health. MtDNA
defects cause dysregulation of multiple aspects of mitochondrial structure and function, known as mitochondrial
allostatic load (MAL). Three main lines of evidence suggest that MAL contributes to AL and regulates stress
responses in humans: i) we recently discovered that the mtDNA is released following psychological stress in
humans (PNEC 2019), ii) experimentally-induced MAL in animals caused specific alterations in the multisystem
physiological responses to psychological stress (PNAS 2015), and iii) mitochondria are the source of stress
hormones, including cortisol that is synthesized in mitochondria within the adrenal glands (Nat Genetics 2012).
Together, this evidence suggests that MAL may alter both baseline AL and stress reactivity profiles, potentially
providing new insight into the source of interindividual differences in stress regulation and health in general. In
this project, we perform the first comprehensive assessment of MAL, systemic AL, multisystem stress reactivity
to a laboratory challenge (TSST) in three groups of individuals who have rare genetic mtDNA defects that
selectively causes different forms of MAL and in a healthy control group. Multisystem stress biomarker profiling
under fasting baseline and stress reactive conditions will provide a comprehensive test of pathways linking MAL
to stress physiology in humans. The resulting high-dimensionality data will be treated using integrative data
analytic approaches and classifying algorithms, including cross-validated machine learning models, to identify
resting and stress-reactive biomarker signatures responsive to MAL. In parallel, assessments of executive
function and key domains of psychosocial functioning including mood, stress, anxiety, depressive symptoms,
and well-being will contribute to provide a comprehensive picture of novel mitochondrial psychobiological
pathways.

Public health relevance
NARRATIVE There are large unexplained inter-individual differences in systemic allostatic load and stress reactivity, which may in part be explained by mitochondria. Here we study the effects of chronic dysregulation of mitochondrial function – mitochondrial allostatic load (MAL) – on multisystem stress regulation in humans. This project will establish the influence of MAL on baseline AL as well as multisystem stress reactivity profiles, defining novel psychobiological pathways by which mitochondria may contribute to the maintenance of health and resilience, and to disease risk.